Epigenetic Regulation of Melanoma-Associated Fibroblast Plasticity

PROJECT SUMMARY
Histone variant dysfunction has profound consequences for tumor cells; however, their role in the tumor
microenvironment (TME) remains unclear. Using an autochthonous, immunocompetent BRAFV600E/PTEN-
deficient primary melanoma model, I showed that mice devoid of macroH2A (dKO) develop larger tumors,
accompanied by accumulation of immunosuppressive monocytes and depletion of functional cytotoxic T
cells. This compromised anti-tumor response stems from intrinsic upregulation of inflammatory genes,
including Ccl2, Cxcl1 and Il6, in cancer-associated fibroblasts (CAFs), whose frequency and activation increase
in the absence of macroH2A. dKO CAFs also downregulate myofibroblast-associated genes, raising the
possibility that macroH2A impacts fibroblast polarization during tumor progression, skewing the balance between
inflammatory (iCAFs) and myofibroblast (myCAF) subtypes. Mechanistically, this novel function
for macrohistones in the melanoma TME involves 3D chromatin organization, as we found that macroH2A loss
leads to increased looping between inflammatory genes and active enhancers.
We hypothesize that epigenetic modulation of CAFs could direct their phenotype, in turn affecting immune cell
activity in the melanoma TME. I aim to define how CAF hyper-activation in the absence of macroH2A shapes
tumor initiation and the ensuing immune response. To this aim, I will leverage primary CAF cultures derived from
human melanoma (PDMCAFs). I will first characterize how transcription of macroH2A genes is regulated in
PDMCAFs to give rise to variable macroH2A levels. Next, I will establish to what extent PDMCAF cultures
represent the functional CAF subtypes present in vivo in melanoma. Third, I will determine if macroH2A
epigenetically regulates inflammatory gene loci in human cells by coordinating chromatin looping. Finally, I will
test if macroH2A deficiency skews fibroblast polarization towards an inflammatory vs. myofibroblastic phenotype
in CAFs during tumor progression.
Therapeutic approaches that leverage the TME, such as immunotherapy, cure a subset of otherwise deadly
melanomas. However, CAF plasticity hampers their efficacy and can have both tumor-promoting and restraining
effects. The published study I led was the first to demonstrate a role for a histone variant in modulating the
inflammatory properties of the melanoma stroma. Addressing whether similar mechanisms affect CAF plasticity
in human melanoma is particularly timely, as epigenetic deregulation may promote a "cold" immune
microenvironment. Therefore, this proposed project will make an important contribution to understanding how
epigenetic deregulation within the TME could potentially impact melanoma initiation, response to therapy,
progression, recurrence, and/or dormancy.

Public health relevance
PROJECT NARRATIVE Histone variants have specialized functions within the chromatin template and their dysfunction contributes to cancer, either by driving abnormal gene expression programs in malignant cells, or by reprogramming non- malignant cells of the tumor microenvironment towards cancer-associated fates. Using unique patient-derived cells, coupled to advanced epigenomic techniques, we aim to dissect the role of macroH2A histone variants in regulating pro-inflammatory signals produced by cancer-associated fibroblasts. Our studies will elucidate how macroH2A shapes the tumor microenvironment to potentially impact melanoma initiation, response to therapy, progression, recurrence, and/or dormancy.